CATCH: Creating Access to Transplant for Candidates who are High Risk

PROJECT SUMMARY
Today, lung transplantation for patients with end-stage lung disease has become increasingly standardized
around the world, thanks to decades of international collaboration and partnership. As a result, more patients
can receive a life-saving procedure and benefit from vastly improved survival and quality of life.
However, access to lung transplant remains particularly variable for three categories of high-risk patients: 1)
highly sensitized patients; 2) patients requiring extracorporeal membrane oxygenation support as a bridge to
transplant (ECMO-BTT); and 3) patients with acute respiratory distress syndrome (ARDS, including those with
COVID-19-associated ARDS). Because these patients are at high-risk for complications and historically
understudied, there are no clear guidelines for their treatment. As a result, they are uniquely disadvantaged:
receiving a transplant largely depends on their program’s willingness to accept the risk of transplant without
sufficient data to inform how it can be optimally and safely performed. Programs, therefore, differ in the
selection and management of these patients, creating significant disparities and variation in care across
centers, ultimately to the detriment of the transplant candidate.
With support from the NIH Lung Transplant Consortium, we propose the formation of CATCH: Creating Access
to Transplant for Candidates who are High Risk, with the goal to improve access and outcomes for these
patients in need. The four lung transplant programs that comprise CATCH—University Health Network,
University of Florida, Columbia University, and Brigham and Women’s Hospital—collectively perform over 400
lung transplantations per year, and each have extensive but differing experience in managing these patients.
Our CATCH study hypothesis is that our individual management strategies significantly impact high-risk
candidates’ likelihood of receiving a transplant and their post-transplant outcomes. Through prospective
cohort studies, we aim to devise an optimal and united strategy that addresses the specific unmet needs of
these high risk patients.
Our team has been carefully assembled based on scientific merit and strategic collaboration, representing
multidisciplinary strengths in thoracic surgery and lung transplant pulmonology that will complement our
recognized research leadership. We have extensive experience in successful project management for large
multi-site projects, and our expertise in developing standardized protocols and consensus documents will help
to maximize the potential across all transplant centers. Ultimately, as key opinion leaders in a field that actively
looks to us for guidance, our CATCH project outcomes are strongly positioned to have an immediate
transformative impact by standardizing the field and ensuring that every patient in need of a lung transplant
can receive one.

Public health relevance
Project Narrative Globally, access to lung transplantation for high risk patients varies significantly due to a lack of consensus regarding their eligibility. Our project will compare how different lung transplant centers manage these patients, which will help us to develop new standard guidelines for their care. Ultimately, this will allow more patients to receive a surgery that reduces their illnesses and saves their lives.